Estrogenic signaling upstream and downstream of mTOR

Abstract
Work in the Holz lab focuses on the crosstalk between estrogen signaling and mTOR (mechanistic target of
rapamycin), two fundamental pathways that regulate growth and proliferation in the cell. One of the major
unanswered questions is how cytoplasmic signaling by estrogen activates mTOR, and what downstream
mTOR effectors are the specific targets of estrogen. This question represents a major gap in our
understanding of the relationship between estrogen and mTOR signaling, with relevance to normal cell
homeostasis and inappropriate signaling in many estrogen-dependent diseases. Two related projects stem
from our published and preliminary data. First, we will examine how mTOR is activated by estrogen, and what
downstream cellular events are initiated. To accomplish this goal, we will use quantitative proteomics and
phosphoproteomics for signaling pathway discovery, followed by biochemical investigation and cell biology-
based studies of estrogen- and mTOR-regulated proteins. Second, we will investigate the control of protein
synthesis by estrogen. While regulation of transcription by estrogen is well studied, we propose to investigate
an unexplored role for estrogen in mediating translational control. We will employ polysome profiling coupled
with RNA-seq to identify translationally regulated estrogenic targets. The proposed research program will
combine our interests in estrogen signaling and mTOR-regulated translational control, will allow us to freely
generate new data and to explore exciting directions.

Public health relevance
PROJECT NARRATIVE Our proposal focuses on investigating the molecular mechanism by which Estrogen Receptor cooperates with the mechanistic target of rapamycin (mTOR) signaling in regulating cellular processes in homeostasis and disease. Specifically, we would determine how estrogen activates mTOR, and what downstream processes are subsequently affected.